Regulation and Cellular Functions of V-ATPases

PROJECT SUMMARY
V-ATPases are versatile, highly conserved, multi-subunit proton pumps responsible for organelle acidification
in virtually all eukaryotic cells. Complete loss of V-ATPase activity is lethal in all eukaryotes except fungi, but
mutations in subunit isoforms are linked to distal renal tubule acidosis, infertility, deafness, and osteopetrosis.
V-ATPase activity is subverted in cancer to support additional demands on cellular pH homeostasis and
promote metastasis by creating an acidic extracellular environment. Endosomal acidification by V-ATPases
also promotes entry of many viruses. There is a crucial need to understand the roles and regulation of V-
ATPase subunit isoforms and enzyme subpopulations in order to target of V-ATPases in specific locations
therapeutically. V-ATPases are regulated by reversible disassembly of the peripheral V1 subcomplex from the
integral membrane Vo subcomplex, and RAVE/Rabconnectin-3 complexes play a critical role in this process.
We will investigate the structure, mechanism, and subunit composition of the yeast RAVE and mammalian
Rabconnectin-3 complexes, which appear to target specific V-ATPase subunit isoforms as part of their activity.
Importantly, mutations in Rabconnectin-3 complexes have been associated with epilepsy and
neurodegeneration but the underlying disease mechanism is unclear. We previously demonstrated in yeast
that organelle-enriched phosphoinositide phospholipids bind differentially to the two a-subunit isoforms of the
Vo subcomplex, providing organelle-specific inputs into V-ATPase localization and activity. Similar lipid
interactions are observed with mammalian a-subunit isoforms in vitro, and we will extend these studies to
characterizing the effects of the interactions in cultured mammalian cells. Finally, although V-ATPases must
function in concert with other cellular mechanisms of pH homeostasis, the underlying mechanisms of this
coordination are not understood. We will address this question in yeast, where we have discovered that acute
or chronic loss of V-ATPase activity triggers endocytosis of a portion of the major H+ export pump, Pma1, from
the plasma membrane. We will determine the mechanism of this vacuole to plasma membrane pH crosstalk.
Reduced vacuole/lysosome acidification is an early step in aging in both yeast and mammalian cells. We will
assess whether aging yeast cells display a loss in coordinated pH homeostasis or emerging defects in the V-
ATPase itself and determine whether these processes can be manipulated.

Public health relevance
Narrative of Public Health Relevance V-ATPases are present in all cells and help control pH in specific sub-compartments, degrade defective proteins, and respond to environmental stresses. Their dysfunction is associated with diseases like Alzheimer’s disease, cancer, and osteoporosis. V-ATPases are involved in many functions, and it is hard to target subpopulations of V-ATPases therapeutically. We are characterizing regulators of V-ATPases in specific locations. Targeting these regulators might make it possible to treat diseases associated with aberrant V-ATPase activity.